MS/AL Radiation Oncology Research Partnership

at the top of each pdnted page and each continuation page. RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page .................................................................................................................................................. 1 2 Description,